Defining synthetic lethal relationships with loss of the homologous recombination factor Rad52

SUMMARY. The long-term goal of this project is to define factors and pathways that are synthetic lethal with
loss of the human Rad52 protein. Rad52 plays essential roles in several homology-driven DNA repair pathways,
including single strand annealing, transcription-coupled homologous recombination, and mitotic DNA synthesis
(MiDAS). Although Rad52 is not essential, Rad52 loss with disruption of either the breast cancer 1 (BRCA1) or
breast cancer 2 (BRCA2) genes is synthetic lethal. Thus, Rad52 is an intriguing potential target for treatment of
BRCA-deficient cancers. However, the full breadth of pathways and factors that create a state of Rad52-
dependence when compromised are not understood, and the long-term goal of this proposal is to address this
gap in knowledge. In preliminary data, I present my CRISPR knock-out screen in Rad52 Knock-out (Rad52KO)
cells vs. wild-type (Rad52WT) to identify factors that are synthetic lethal with Rad52 (defined here as loss of
fitness). I then present secondary screening that identified three top hits causing increased persistent DNA
damage and loss of viability in the Rad52KO vs Rad52WT: ERCC6L/PICH, DHX9 and GLE1. From these data, my
overall hypothesis is that a key regulator of Mitosis (PICH) and RNA metabolism factors (DHX9 and GLE1) are
synthetic lethal with Rad52 due to dependence on Rad52 to resolve replication stress from diverse sources. Aim
1: To define the synthetic lethal relationship between Rad52 and PICH. Rad52 protects genome stability through
roles in MiDAS and suppression of replication stress. PICH mediates resolution of anaphase ultrafine bridges
(UFBs), a separate pathway to mitigate replication stress. Aim 1a: I posit that these two pathways are partially
redundant in preventing accumulation of genotoxic damage tied to replication stress. Namely, I posit that PICH-
UFBs will be elevated in Rad52KO cells, and conversely that depletion of PICH will cause elevated Rad52
recruitment to replication stress in mitotic cells, as well as MiDAS. Aim 1b: I also posit that replication stress that
persists until mitosis is the source of persistent DNA damage in cells lacking Rad52 and PICH. I will test this by
assaying phosphorylated RPA2 (pRPA), γH2AX, and FANCD2 localization in mitotic cells. Aim 2: To define the
synthetic lethal relationship between Rad52 and RNA metabolism factors DHX9 and GLE1. DHX9 and GLE1
have been shown to suppress RNA-DNA hybrids (R-loops). Thus, I hypothesize that R-loop-related replication
stress underlies synthetic lethality between these genes and Rad52. I will assay whether depletion of these
genes increases R-loops, causes elevated levels of mitotic replication stress (i.e. Rad52 accumulation into foci,
MiDAS, PICH-UFBs, and the measures of replication stress described in Aim 1b). In summary, these studies will
provide insight into how loss of these genes create a dependence on Rad52-mediated mitigation of replication
stress in mitosis (i.e., MiDAS), enhance our understanding of genome maintenance mechanisms, with a long-
term goal of identifing tumor-specific vulnerabilities for Rad52 inhibitors.

Public health relevance
NARRATIVE. The homologous recombination factor Rad52 is being investigated as a target for synthetic lethal approaches for cancer therapy. To realize the full potential for this targeted therapeutic approach, it is critical to define the complete range of factors and pathways that are synthetic lethal with loss of Rad52. Thus, my proposed studies to investigate the synthetic lethal interactions with loss of Rad52 for the F32 award support the NIH mission to improve cancer patient outcomes.